Identification of Comorbid Language and Reading Disorders in SpanishEnglish Bilingual Children

PROJECT SUMMARY
Children with a developmental language disorder (DLD) are roughly five times more likely to struggle with
reading when they reach school age than a child without language issues. Given the frequent co-occurrence of
language and reading disorders, early identification of children with DLD is critical for mitigating long-term risk
in reading. This is particularly important for bilinguals (English learners/dual language learners). One in 5
children in the U.S. begins school speaking a language other than English; however, there is a stark shortage
of diagnostic screening tools that can be administered with young bilingual children to identify language and
possible concomitant reading disorders. The proposed project will develop and pilot a novel sentence repetition
task for the differential diagnosis of DLD and/or dyslexia in bilinguals. Sentence repetition taxes both
grammatical ability and phonological processing ability—two areas commonly affected in language and reading
disorders, respectively. Deficits in sentence repetition performance have been reported among children with
DLD (Archibald & Joanisse, 2009), dyslexia (Moll et al., 2015), and concomitant DLD+dyslexia (Bishop et al.,
2009). Critically, sentence repetition has also shown high levels of specificity and sensitivity when used to
identify disorders in bilingual children (Pratt, Peña, & Bedore, 2020), who are still in the process of developing
their grammatical and phonological representations. In year 1, the Principal Investigator will develop an initial
set of 48 sentence repetition items in English and Spanish (24 per language) that systematically vary in their
inclusion of grammatical and phonological targets. In years 1-2, 150 school-age Spanish-English bilingual
children in Southern California will be recruited. Based on clinical referral and children’s performance on
reference measures of language and reading ability, participants will be accrued into diagnostic groups:
bilinguals with DLD (n=25), bilinguals with dyslexia (n=25), and bilinguals with comorbid DLD+dyslexia (n=25).
Bilingual children who do not fit a diagnostic group will serve as typical language and reading controls
(expected n=75). The novel sentence repetition task will be administered to all participants. Participants will
also complete a brief supplemental battery of phonological processing tasks, to explore linguistic and
phonological predictors of performance. Pilot data will guide an iterative process of culling and revising test
items. Person-item leaf plots, as well as information function, will examine the distribution of correct responses
across diagnostic groups. Concurrent validity will be evaluated by examining the correlations between
sentence repetition and the reference measures. Predictive validity will be evaluated in year 3.

Public health relevance
PROJECT NARRATIVE The proposed R21 aims to improve screening procedures of developmental language disorder (DLD) and dyslexia in Spanish-English bilingual children through the development of a novel sentence repetition screener. Findings will help to guide identification practices for bilingual children with language and reading disorders. Early identification is needed to ameliorate long-term negative effects associated with DLD and possible concomitant reading disorders, which include academic underachievement and low occupational attainment.